Diversity Supplement: Molecular probes to image and target the neurovascular unit in health and disease

Not required for this Supplement RFA

Public health relevance
Not required for this Supplement RFA